Mechanism of p53-dependent Tumor Suppression

Project Summary/Abstract
p53 tumor suppressor is frequently mutated in cancer, and mutant p53 is an oncogene. Upon exposure
to a stress signal, such as DNA damage, p53 transcription factor is activated and then induces an array of
pro-survival and pro-death genes. Among these is Rbm38, a RNA-binding protein. Interestingly, we
showed that Rbm38 represses p53 mRNA translation by preventing eIF4E from binding to p53 m7G cap.
Thus, p53 and Rbm38 constitutes a feedback loop. To determine the significance of the p53-Rbm38
loop, we showed that:(1) phosphorylation of serine-195 and substitution of S195 with aspartic acid
(S195D) prevent Rbm38 from interacting with eIF4E, which converts Rbm38 from a repressor to an
activator of p53 translation; (2) an 8-aa peptide derived from Rbm38 (Pep8: YPYAAS195PA) and a 23-
aa peptide derived from eIF4E (Pep23: aa 195-217) are able to disrupt the Rbm38-eIF4E complex to
increase p53 expression. These observations prompt us to hypothesize that the Rbm38-eIF4E pathway,
which is regulated by S195 phosphorylation and mutations in Rbm38, plays a critical role in p53-
mediated tumor suppression. To test this, we will determine: (1) how p53-dependent tumor suppression
is regulated by the Rbm38-eIF4E pathway; (2) whether the Rbm38-eIF4E pathway can be targeted to
kill tumor cells carrying wild-type p53.

Public health relevance
Project Narrative The proposed study is highly significant and relevant to human health: (1) this study would provide better understanding of p53 biology and how p53-dependent tumor suppression is regulated by the Rbm38-eIF4E pathway; (2) This study would reveal whether the Rbm38-eIF4E pathway can be targeted to kill tumor cells carrying wild-type p53.